Immune perception of bacterial pathogens in plants

PROJECT SUMMARY/ABSTRACT
The research in this proposal centers on how plants detect and respond to bacterial pathogens through their
immune system. Plants are equipped with a complex innate immune system, consisting of genetically encoded
immune receptors that can identify various pathogens. These receptors bear structural resemblance to those in
animals and include both surface-bound pattern recognition receptors (PRRs) and internal nucleotide-binding
leucine-rich repeat (NLR) receptors. Plant PRRs, which are either receptor-like kinases or proteins, can detect
conserved pathogen or damage-associated molecular patterns (PAMPs/DAMPs). NLR receptors can identify a
range of pathogen effector proteins that invade plant cells during infection, leading to programmed cell death at
the infection site. Our research will delve into the spatial organization of immune responses, the specificity of
immune receptors, and how pathogen variation affects PRR detection. We aim to understand the role of cell
death in releasing DAMPs to hinder pathogen spread at the site of infection. Additionally, we will explore how
PRR recognition specificity and signaling are regulated, using natural variation as a reference. Our
investigation will also cover the effects of variation in pathogen epitopes on immune signaling and PAMP
functionality. Through this project, we aim to train emerging scientists and achieve breakthroughs that deepen
our comprehension of how initial pathogen detection signals are integrated into an effective defense strategy.

Public health relevance
PROJECT NARRATIVE The proposed research aims to explore the mechanisms by which plants detect bacterial pathogens and trigger immune responses, emphasizing precise spatial analysis. Given the parallels in immune receptors and signaling processes between plants and vertebrates, we expect that our findings will significantly contribute to a wider comprehension of immune detection and signaling mechanisms.